MicroRNAs in Alcoholic Liver Disease Administrative Supplement

ABSTRACT
Both Alzheimer’s disease (AD) and alcohol-related dementia (ARD) are also rapidly increasing in the US. Both
types of dementias exhibit memory loss and their pathomechanisms involve neuroinflammation and microglia
activation Heavy alcohol use was can also increases the risk of AD. microRNA-155, a small non-coding RNA
involved in regulation of inflammation, is upregulated in the brain in AD as well as in ARD. We showed that
alcohol-induced neuroinflammation is attenuated in miR-155 deficient mice. Deletion of miR-155 also protected
against memory deficits and neuroinflammation in a mouse model of AD. Based on these observations, we
hypothesize that miR-155 upregulation in microglia plays a regulatory role in alcohol-induced as well as in AD
neuroinflammation and memory deficits. We showed before that miR-155 also regulates the biogenesis of
exosomes that are small extracellular vesicles (EVs) in macrophages. Here we will evaluate the role of miR-155
is in EV production in microglia. Further, we will assess miR-155 or other RNA components of EVs in AD and
after alcohol exposure. Our hypotheses will be tested in the following Specific Aims: Aim#1 will evaluate the
role of miR-155 on EV production and the EV cargo in vitro in microglia cultures by a) evaluating alcohol
and Aβ-induced EV production in primary microglia from wild-type and miR-155 knockout mice; b) testing the
effect miR-155 overexpression and knockdown on alcohol and amyloid beta (Aß)-induced EV production in BV2
cells; c) testing the effects of EVs derived from alcohol- or Aβ-stimulated microglia on activation of “naïve’
microglia. Aim#2 will investigate the role of miR-155 deletion on alcohol-induced memory deficits in
C57/Bl6 (WT) and AD (5X FAD) mice in correlation with neuroinflammation and EV production by: a)
assessing memory performance of mice in Morris Water Maze, b) enumerating EV levels from the brain tissue
and characterizing the miRNA cargo of isolated EVs, c) evaluating the activation state of alcohol-induced
microglia by transcriptomic profiling and neuroinflammation markers. Results from these experiments will provide
novel insights into the role of miR-155 in alcohol-induced and AD-related memory loss, EV production and
neuroinflammation.

Public health relevance
NARRATIVE The most common causes of dementias are Alzheimer’s disease (AD) and alcohol use that when combined, worsen memory functions. Activation of inflammatory processes in the brain, particularly in microglia cells is a major driver of disease. In this proposal we will evaluate the role of a small non-coding RNA, miRNA-155, development of memory deficit and neuroinflammation and explore the role of extracellular vesicles in this process.